POP2 as a novel therapeutic in rheumatoid arthritis

Project Summary:
Inflammation underlies the disabling manifestations and co-morbidities of rheumatoid arthritis (RA). Treatment
regimens for RA patients aim to control inflammation and progressive joint damage mediated by inflammatory
cytokines including TNFα, IL-1β, and IL-6. Recent studies demonstrate that humans possess four genes
coding Pyrin-only proteins (POPs) that limit NF-B signaling and inflammasome activation pathways, events
critical for elaboration of the cytokines mediating inflammation. TNF, IL-1β, and IL-6 are critically regulated by
NF-B transcription factors. We have previously described the anti-inflammatory properties of POP2 in-vitro
and in-vivo. Here we propose proof-of-concept studies to evaluate how POP2 and POP2-derived peptides
impact experimentally induced RA when administered exogenously, using a murine preclinical model. POP2
peptide therapy represents a novel therapeutic approach to ameliorating excessive inflammation through dual
inhibition of both NF-B signaling and inflammasome pathways. The immunological and molecular basis for
our hypotheses stems from our published and preliminary data showing the naturally expressed, non-toxic
POP2 peptide dampens cytokine production in inflammatory responses without compromising host immunity.
Our studies will provide insight into how treatment regimens based on POP2 peptide therapy may be utilized or
improved upon. In vitro characterization, dose-escalation studies and in-vivo assessment of disease
parameters will inform approaches to develop POP2 peptides as a novel therapeutic.

Public health relevance
Project Narrative: Chronic, progressive, and debilitating inflammatory diseases including Rheumatoid arthritis (RA) afflict millions of Americans each year. Despite sophisticated biologic therapies, severe inflammation continues to reduce the quality of life for many patients. A class of understudied, naturally expressed human proteins (Pyrin-only proteins; POPs), absent in mice and other common laboratory animals, have been implicated as important regulators of inflammation that constrain NF-kB signaling and inflammasome-mediated inflammatory pathways. We have previously described the anti-inflammatory effects of POP2, which holds promise as a novel therapeutic. However, new proof-of-concept studies are needed to advance the investigation of this hypothesis. We propose evaluating the ability of POP2 peptide therapy to reduce inflammation in a mouse model of RA. If successful, these studies will reveal a novel therapeutic approach to limiting inflammatory responses.